Reconstructing the Global Epistasis Network for Aging

Project Summary
Research in the biology of aging has seen rapid advance since the introduction of molecular genetics to the
field. In the past few decades, genetic analyses of model organisms have led to the discovery of a number of
genes/pathways that regulate lifespan, leading to important insight into the mechanisms of aging. However a
global picture of the gene network that regulates lifespan is still elusive. To classify longevity mutants based on
their mechanisms of action, to place genes influencing lifespan into pathways, and to delineate the
downstream effectors of the lifespan extension for the longevity mutants, it is necessary to systematically
analyze the epistatic relations between genes for the lifespan phenotype. So far this has not been possible in
any model organism due to the sheer number of double mutants that need to be analyzed and the low
throughput nature of the traditional lifespan assays.
Here we propose to systematically reconstruct the global epistasis network for aging using budding yeast as
the model organism and replicative lifespan as the phenotype. We will develop a high throughput approach to
generate all possible single and double mutants and measure their lifespan simultaneously (Aim 1). Our
approach will be based on a number of new technologies: 1) a novel genetically engineered strain that makes
it possible to measure lifespan based on cell counting in liquid culture; 2) CRISPR/dCas9 based technology to
generate a pooled library of single and double mutants, each carrying a unique DNA sequence identifier; 3)
high throughput sequencing to count the number of cells of the pooled mutants simultaneously. We will use the
comprehensive lifespan data to reconstruct the global epistasis map through computational analysis. We will
also test some of the discovered epistatic relations both in yeast and in worms (Aim 2).
We expect that this project will produce unprecedented and comprehensive data on the epistasis network that
controls lifespan in a canonical model organism. The analysis of this data will lead to important insights into the
functional organization of genes in the context of aging and mechanisms for the lifespan extension in long-lived
mutants. Such insights might be transferrable to higher eukaryotes, in which a systematic reconstruction of the
epistasis network for aging is not feasible.

Public health relevance
Project Narrative Genetic analyses of model organisms have revealed many genes that influence lifespan. However the functional organization of these genes and the mechanisms through which they influence lifespan remain elusive. This project proposes a high-throughput approach to systematically analyze the genetic interactions between genes at a genome-wide scale in the context of aging. New technologies will be developed to measure the replicative lifespan of yeast for all single and double mutants. The comprehensive lifespan data will then be used to reconstruct the global epistasis network regulating lifespan. The project will generate genetic interaction data for aging at an unprecedented scale and shed important light on the mechanisms for lifespan regulation.